A Digital Biomarker for ALS - Pison Neural Biosensor

Amyotrophic lateral sclerosis (ALS) is a lethal degenerative neurological disease with progressive
loss of all motor function and no known cure. Disease management is largely palliative. The
landscape of ALS management is changing with the arrival of newly approved therapies and with
other disease-modifying drugs on the horizon. This change prioritizes the need for early
identification and monitoring of disease before the inexorable loss of motor neuron function.
Pison has previously created a mobile wrist-worn device that uses surface electromyography
(sEMG) to generate data in real time, continuously, and remotely, generating high-fidelity
neurologic signals. This physiologic data is then cleaned, characterized, and labeled
instantaneously by cloud-based algorithms and immediately available for use. The work to date
has used this physiologic data to enable gesture control of third-party devices.
The purpose of this fast-track Phase I / Phase II proposal is to assess the Pison Neural Biosensor
as a scalable source of a digital biomarker for the characterization of disease progression in ALS.
This previous work done both in patients with ALS and in healthy populations partially de-risks
the project, providing confidence in Pison’s ability to deliver a data-driven digital biomarker for this
disease obtained from an easily deployable device that serves the needs of this specific
population.
The data obtained will have the fidelity and reliability to inform the creation of a disease biomarker
measurable remotely, in the home of persons with ALS (pALS), and will provide a significant
advancement in the diagnosis and monitoring of this patient population. This will aid in the rapid
understanding of the patient’s condition and the effect of treatment and allow for more prompt
responses to clinical changes. Such a biomarker will be highly innovative in this disease state, as
well as in other neurodegenerative diseases in the future.
It is Pison’s goal in Phase I of this grant to create a version of our neural sensor that can be used
by pALS in a clinical setting, with the assistance of clinical personnel.
If this goal can be accomplished, as defined by specific usability and data quality metrics, Phase
II will focus on developing a digital biomarker that will allow identification and tracking of pALS in
a scalable and remotely deployable system that can be used without clinical assistance in the
patients’ home.

Public health relevance
Project Narrative Pison will utilize the high fidelity surface electromyography signals obtained through its wearable device in the amyotrphic lateral sclerosis (ALS) population to obtain neural insights on the disease. This development of a “digital biomarker” for ALS will have an extremely positive effect on the entire ALS community by allowing patients, families, physicians, researchers, and pharmaceutical companies to identify disease and track progression in a frequent (even continuous) and real-time manner, bringing the goal of personalized care to patients. The distributed nature of the Pison platform will reduce health disparities by allowing for remote monitoring in patients homes and even early identification of disease in those at risk, but still in a pre-clinical state.